An Integrated microbiota-gut-brain axis model for Hypertension Signaling

Abstract
A growing number of conditions have been characterized by changes in abundance and composition of the gut
microbiota, commonly termed the gut dysbiosis. However, the complexities of the host-microbiota interactions
present us with difficulties in elucidating mechanistic pathways for development of new therapeutics. In our
rodent model of gut dysbiosis-induced hypertension, reduced abundance of Akkermansia muciniphila
(A.muciniphila) was associated with reduced colonic serotonin (5HT) and diminished expression of serotonergic
5HT3a receptors (5HT3aRs) on gut vagal afferents. Using an intersectional viral approach in transgenic 5HT3aR
Cre rats, we show that the colon-projecting 5HT3aR-expressing gut vagal afferents are necessary for
maintenance of blood pressure homeostasis, and that administration of A.muciniphila can reduce blood pressure
in hypertensive rodents. However, whether the blood pressure-lowering effects of A. muciniphila are mediated
via the gut epithelial 5HT and vagal afferent 5-HT3aR signaling is unknown. Thus, a reductionist approach that
mimics the in vivo gut microbiota microenvironment, in which the conditions of each compartment can be
independently manipulated and functionally investigated, may be beneficial for initial mechanistic and functional
screening of gut bacterial effects on the host neuronal signaling that is mediated via the gut epithelium. We
developed a microfluidic tri-culture model that allows side-by-side co-culturing of anaerobic gut bacteria, colonic
epithelial cells, and vagal sensory neurons in a microfluidics device in vitro. This will allow semi-high throughput
screening of select bacterial effects on colonic 5HT and vagal 5HT3aR-dependent signaling by live imaging of
calcium-dependent neuronal activity in tri-culture. This is an innovative approach that expands on the capabilities
of the currently available dual compartment microfluidics devices and organs on chip by adding the third
manipulable microbiota anaerobic compartment, but further developments of the device are necessary for full
realization of its potential. To aid with this, the in vitro investigations will be functionally validated in vivo in a
rodent model of gut dysbiosis-associated hypertension in which the activity of the gut-projecting vagal 5HT3aR
afferents can be manipulated using an intersectional Cre-FLPo recombinase strategy. This will allow
investigation of a direct causative and mechanistic link between A. muciniphila, serotonergic gut vagal signaling,
and blood pressure. Findings will further our understanding of host-microbiota interactions and support early
phase of research that will yield new models and methodologies which are expected to transition into future grant
funding and potential new therapeutics to restore gut homeostasis and alleviate conditions associated with
dysfunctional gut-brain axis.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will investigate specific mechanisms of interaction between the host and select beneficial gut bacteria for potential use in therapeutics. This proposal directly addresses the strategic goals of the NIH and the current FOA as it uses novel concepts and technologies to better understand health and disease with broad application to multiple NIH Institutes or Centers. Data are expected to be translational for diseases and conditions associated with dysfunctional serotonergic vagal gut-brain axis.